PHASE I TRIAL OF INTRAVENOUS THYMIDINE AND CARBOPLATIN

The purposes of this study are to determine the maximum tolerated dose of carboplatin in conjunction with thymidine, to determine clinical toxicity of thymidine and/or carboplatin, to compare the combination to carboplatin alone, to assess pharmacokinetics of both agents, and to assess antineoplastic effects.